Breaking prolonged sitting with high-intensity interval training to improve cognitive and brainhealth in older adults: A pilot feasibility trial

Abstract
Age is the major risk factor for AD, which affects ~5.8 million Americans. Increasing physical activity (PA) could
decrease the prevalence of Alzheimer’s Disease (AD) and AD Related Dementias by 11%. Yet, the majority of
older adults (54%) remain physically inactive. Traditional PA interventions do not reduce excessive sitting in
older adults. In particular, sitting continuously for 20 min or longer (i.e., prolonged sitting) can acutely reduce
frontoparietal brain function and attentional control. Thus, habitually high levels of prolonged sitting in older adults
(5 h/day) may contribute to the declining efficiency of the frontoparietal brain function with age, negatively
affecting attentional control and consolidation of episodic memories. Accordingly, PA interventions to enhance
frontoparietal and cognitive function in older adults should also target reducing prolonged sitting. However, no
effective PA interventions designed to reduce prolonged sitting and improve frontoparietal brain function,
attentional control, and episodic memory exist. To be effective such interventions should target the mechanisms
underlying PA effects on brain function. A single bout of PA is thought to enhance frontoparietal brain function
by stimulating phasic release of cerebral norepinephrine from the locus coeruleus. Specifically, PA stimulates
vagus nerve in the periphery by increasing levels of peripheral catecholamines. Capitalizing on PA intensity as
the major limiting factor in peripheral catecholamine increase, we propose a pilot randomized crossover
feasibility trial to compare 2 conditions lasting 3.5 h each: sitting interrupted by 6-min HIIT every 30 min (HIIT
Breaks), and sitting interrupted by 6-min social interactions (SIT) to address 3 aims: (i) to assess feasibility,
acceptability, fidelity, and safety of HIIT Breaks to improve neurocognitive function; (ii) to quantify the differences
between conditions in the change in P3b amplitude and latency; (iii) to explore the differences between conditions
in attentional control, episodic memory, and functional connectivity (FC) of the frontoparietal and default mode
networks. We will administer the conditions in a counterbalanced order to 54 older adults (60-75 years). We will
use the P3b component of an event-related potential as a primary outcome because it is a known marker of
frontoparietal brain function, and an index of phasic shifts (e.g., in response to PA) in cerebral norepinephrine
release. It is also reliably modulated by exercise. Next, we will measure FC in the frontoparietal and default mode
brain networks because they are modulated by cerebral norepinephrine, and support attentional control and
episodic memory, respectively. Furthermore, FC in these networks can be improved with a single bout of PA but
declines with age. These results will reveal if short bouts of HIIT can be used as a model to regularly enhance
brain function and cognition, by probing cerebral norepinephrine release in a chronic intervention. Our long-term
objective is to test the chronic effects of HIIT breaks on the integrity of the locus coeruleus, frontoparietal function,
and cognitive functions affected by aging and AD in cognitively healthy and cognitively impaired seniors.

Public health relevance
Project Narrative National trends show high levels of sitting among older adults and high levels of physical inactivity, a risk factor for Alzheimer’s Disease (AD). Our ability to stay focused (i.e., our attentional control) and remember personal events with contextual detail (i.e., our episodic memory) declines with age and in AD but reducing sitting with brief bouts of physical activity could improve these cognitive functions by enhancing the efficiency of the frontoparietal brain function. For the first time, we will investigate the effects of high-intensity interval training breaks in sitting on frontoparietal brain function and patterns of functional connectivity between brain regions that support attentional control and episodic memory in older adults.